Society of Thermal Medicine Annual Conference

DESCRIPTION (provided by applicant): The Society of Thermal Medicine (STM) is the premiere scientific organization where research related to image-guided thermal therapies is represented. STM has an established track record of organizing successful annual meetings. The goals of this proposal are (1) establishing the new image-guided thermal therapy High-Intensity Focused Ultrasound (HIFU or FUS) as major area within STM, and (2) attracting trainees and young investigators towards our annual conference. This will aid the research in these areas to provide a positive health impact on disease amenable to treatment by image-guided therapies.

Public health relevance
PUBLIC HEALTH RELEVANCE: This grant will provide support for the annual meeting of the Society of Thermal Medicine, to provide travel awards that enable young investigators to attend the meeting, and to attract researchers in new areas of image-guided thermal therapies. This will accelerate research and collaboration in this area to provide a positive health impact on disease amenable to treatment by image-guided thermal therapies.